Hippocampal astrocytic Kir4.1 channel function in Type 2 diabetic mice: impact on neuronal hyperexcitability

Epilepsy is one of the most common neurological disorders in the US. Diabetics are a subgroup of patients that
are at increased risk of suffering from this condition, increasing their morbidity and mortality. Whereas, 9.3% of
the United States population has diabetes. It has been shown that uncontrolled hyperglycemia (diabetes)
increases the susceptibility to epileptiform-like activity in the brain but the mechanism is still unknown. There is
a critical need in the identification a potential mechanism that may help link diabetes and seizures. Epilepsy is
caused by a disruption of neuronal communication. One of the factors that may contribute to epileptiform activity
is the accumulation of extracellular potassium [K+]o in active synaptic areas. Astrocytes provide support, deliver
nutrients to neuronal circuits and maintain extracellular ion balance. Furthermore, they are one of the most
abundant cell types in the brain and they have been highlighted in epilepsy mostly due to decreased capabilities
in potassium uptake. One important well-characterized process that relates to epilepsy is the regulation of [K+]o.
The Kir4.1 inwardly rectifying potassium channel (Kir4.1) located in astrocytes surrounding synapses largely
carries out the process of potassium uptake. The rationale for the proposed study is based on our published
data which shows that astrocytes from hippocampal brain slice from diabetic male mice display Kir4.1 channel
protein downregulation and significant decrease in potassium uptake capability. The objective of this project is
to find a relationship between Kir4.1 downregulation and seizure-like events in the brain of diabetic male and
female mice considering sex as a biological variable. Therefore, our Central Hypothesis is that one of the major
causes of the epileptic phenotype in diabetic patients is the inability to buffer excess [K+]o by astrocytes due to
downregulation of the Kir4.1 channel protein. We will address this by measure astrocytic Kir4.1 channel mRNA
and protein levels, test Kir4.1 channel activity in hippocampal astrocytes and assess the epileptiform activity in
hippocampal pyramidal neurons in response to 4-aminopyridine application using electrophysiology in female
mice. Finally, we will characterize and determine if reinstatement of Kir4.1 channels protein in hippocampal
astrocytes via viral delivery will restore astrocytic Kir channel expression, membrane potential, barium sensitive
currents and K+ and further correlate this with neuronal epileptiform-like activity in diabetic mice. These results
will contribute to new information specifically to the knowledge of diabetes (high glucose) in the brain which may
negatively contribute to neurological problems such as the neuronal hyperexcitability seen in epilepsy. Our main
goal is to understand how hyperglycemia affects astrocytic homeostatic functions leading to neuronal
hyperexcitability.

Public health relevance
A high incidence of epilepsy occurs in the diabetic population that affects their quality of life, decreasing their productivity and increasing their mortality. Elucidating the link between diabetes and epilepsy remains a great medical challenge. The proposed studies will examine the downregulation of Kir4.1 channel as a possible molecular mechanism by which hyperglycemia affects astrocytic functions and its relevance to neuronal hyperexcitability seen in epileptic seizure. Our findings will improve current knowledge and help identify novel therapeutic agents for this disease.